Computer-Aided Drug Design Targeting Protein Phosphorylation

The long-term goal of this research is the development and application of computational methods to aid the
design of drugs targeting protein kinases and related proteins. The approval of about 100 protein kinase
inhibitors as drugs for cancer treatment and other ailments has demonstrated protein kinases as important
drug targets. With over 500 protein kinases present in humans and with many mutants driving diseases, many
more drugs can be developed by targeting protein kinases. This renewal application focuses on improving and
validating simulation methods for finding compounds with therapeutically useful drug-binding kinetics, and in
using molecular simulation and docking methods to help find drugs to treat lung cancer patients carrying
specific mutations in the epidermal growth factor receptor (EGFR).
Specific Aim 1a continues to improve the milestoning method for simulating drug-binding kinetics by using
better progress coordinates. Specific Aim 1b performs systematic sensitivity analysis to identify key amino
acids and molecular interactions in protein kinase-ligand systems that determine their dissociation kinetics.
Specific Aim 2 will help predict drug response of lung cancer patients carrying mutations in EGFR. It contains
two sub-aims. Specific Aim 2a performs molecular simulations on mutants of EGFR found in lung cancer
patients to examine their likelihood of driving disease. Specific Aim 2b extends a machine-learning enhanced
ensemble docking method to predicting drug binding to disease-driving mutants of EGFR.
The research is significant in moving simulation methods closer to the stage of practical applications in
proposing compounds that are more likely to present therapeutically useful drug-binding kinetics, and in
developing predictive models to help decide which mutants of EGFR found in lung cancer patients can benefit
from existing drugs. It is novel in extending systematic sensitivity analysis to identify key amino acids and
molecular interactions in a protein kinase-ligand system in determining drug-dissociation kinetics, information
useful for deciphering the mechanism of drug-dissociation kinetics and designing drugs with therapeutically
useful drug-binding kinetics. The predictive model for drug response is unique in considering both the
possibility of a mutant of EGFR to drive disease and to bind drugs. The prediction of drug binding to EGFR
mutants by ensemble docking is enhanced by machine learning leveraging experimental data of drug response
for mutants found in lung cancer patients. Publications and preliminary results have demonstrated the
feasibility of the approaches.

Public health relevance
About 100 small-molecule inhibitors of protein kinases have already been approved as therapeutic drugs, for treating cancers and other ailments. As the family of protein kinases contains over 500 members and various mutants are responsible for causing diseases, many more drugs could be developed by targeting protein kinases. The proposed research improves and applies tools of computer-aided drug design to speed up the discovery of drugs targeting this family of proteins, with an application on lung cancer.